Reducing Bias in AI Algorithms for Gallium-68 PET: A Bioethical Perspective Using Transfer Learning

Abstract
This is a supplemental application under NOT-OD-25-015 to conduct bioethics research and advance capacity
building related to bias in AI algorithms. This project is specific to both bioethics research and capacity building
in bioethics. Bias in AI algorithms can lead to inaccurate predictions, delaying diagnoses, misguiding treatments,
and worsening patient outcomes. Furthermore, biases in AI algorithms can disproportionately affect certain
demographic groups, amplifying existing healthcare disparities and leading to inequitable outcomes. How to
reduce bias, particularly due to insufficient or unrepresentative datasets, is a major concern in healthcare.
Transfer learning offers a promising solution to mitigate data bias when datasets are small or unrepresentative.
This is especially relevant for PET imaging, such as Gallium 68 PET scans, for which datasets are limited. With
support from the parent R01 project, the team has developed a novel transfer learning framework for PET image
quality enhancement. The proposed framework aims to perform pre-training using large-scale high-quality 18F-
FDG PET datasets and then fine-tune on limited Gallium 68 datasets. In this supplement project, we will
comprehensively evaluate the bias-reduction effect of this proposed framework, explore additional bias mitigation
strategies, and investigate potential biases that may rise from transfer learning. Furthermore, we will actively
disseminate our findings to research, educational and clinical communities. Bias in AI algorithms is a pressing
and emerging bioethical issue when adopting AI to clinics. In the era of rapid AI advancements, this study will
provide a robust evidence base to inform and guide future bioethical policies for AI/ML practices, particularly as
pre-training and transfer learning become foundational in developing large healthcare AI models. Furthermore,
this study will also advance AI-bioethics capacity building by: developing transferable frameworks and
methodologies applicable to various biomedical applications, and creating educational resources to address
bioethical challenges stemming from biases in AI algorithms.

Public health relevance
Project Narrative The proposed research will build new aims related to bioethics research onto the parent study “Deep Learning Methods for Improving Gallium 68-Based PET Imaging” (R01 EB034692). This project aims to evaluate the bias mitigation effect of transfer learning for PET image quality enhancement and examine the potential additional bias that might be caused by pre-training under different experimental settings. Success of this project can enable better understanding of transfer learning regarding bias reduction for medical imaging applications.